Metabolite sensing in a polymicrobial infection

Project Summary
Many bacterial infections are caused by diverse microbial communities. These polymicrobial infections often
result in higher bacterial burdens and more severe disease than single-species infections, a phenomenon called
“synergy”. While synergy between bacteria has been recognized for over a century, the molecular mechanisms
that cause it have proven difficult to elucidate. My laboratory has focused on synergistic interactions between
the opportunistic oral pathogen Aggregatibacter actinomycetemcomitans (Aa) and the human oral commensal
bacterium Streptococcus gordonii (Sg). In the previous grant cycle, we showed that synergy in Aa/Sg co-
infections is caused by several processes involving Aa's utilization of, and response to, the Sg metabolites L-
lactate and H2O2. The goal of this renewal is two-fold: 1) to determine how the Aa-Sg synergy mechanisms that
we have discovered impact robustness to environmental disturbances and to determine precisely how the spatial
organization of these species impacts such interactions during infection (Specific Aims 1 & 2); and 2) to utilize
high-throughput genomics to define the metabolic interactions that occur between Aa and a range of co-infecting
bacteria (Specific Aim 3).

Public health relevance
Public Health Relevance Many bacterial infections are caused by complex microbial communities, and interactions between community members often enhances disease severity. The primary objective of this research proposal is to define how interaction between bacteria in the oral cavity lead to severe infections both inside and outside the oral cavity. The ultimate goal is to guide development of novel therapeutic strategies that interfere with bacterial interactions during infection.